CGS 12970 IN CYCLOSPORINE NEPHROTOXICITY IN RENAL ALLOGRAFT RECIPIENTS

The purpose of this study is to examine the safety and tolerability of CGS 12970 administered orally at the dose of 400 mg/daily for 28 days; and to examine the effect of CGS 12970 compared to placebo on urinary eicosanoid excretion.